Pilot and Feasibility Program

Summary
The proposed Pilot and Feasibility (P/F) Program is an extension of the similar effort supported by the NIDDK-
funded Mini-Center held at the University of California San Diego (UCSD) for four years and subsequent
extension of the Program with institutional resources. In view of the success of the past and current Program,
we have received outstanding institutional commitment to double the funds provided by a Silvio O. Conte Center
in Digestive Disease Research to support innovative new awards for young scientists beginning their careers.
The P/F program will also be used to attract investigators with outstanding expertise into the area of digestive
diseases research that is focused on the central theme of inflammation in the gastrointestinal tract and liver. The
objective of the P/F Program is to make research funds available to a broad swath of talented investigators and
promising trainees within the San Diego Digestive Diseases Research Center and to facilitate the transition
from pilot projects to research grants funded by extramural sources. To achieve this objective, we will use a P/F
Scientific Review Committee chaired by an experienced faculty from outside of the Center. The members of this
committee will be from the Internal Advisory Board and represent all thematic areas and institutions in addition
to UCSD. Announcements will be widely broadcast well in advance before deadlines to the faculty in each of the
Center institutions. All applications will be reviewed by experts in the field and each application will include a
review from outside the Center. The Chair of the P/F Scientific Review Committee will tabulate scores and
convene a meeting to discuss rankings and budgets. A pay plan will be recommended to the Executive
Committee and discussed with the External Advisory Committee, and awards will be announced. Post-award,
the Director of the P/F Program will follow up with unfunded applicants to discuss improvements for future
considerations. In addition, the P/F Program Director and one or several of the Core Directors and Co-Directors
will meet twice a year with each awardee to review progress, encourage them to access the expertise and
services within the Cores and note their progress towards an application for extramural funding. Thus, the P/F
Program will greatly benefit the investigators in the Center by providing funds to support new projects and career
development in research related to the digestive tract and liver.